SynthoPlate: Intravenous Hemostatic Nanotechnology to Mitigate Bleeding in Thrombocytopenia

Project Summary/Abstract
The normal platelet count in human blood is 150,000-400,000/μL, and these platelets are responsible for efficient
hemostatic surveillance and bleeding mitigation in the body. Thrombocytopenia (TCP, low platelet count) is a
condition caused by a decrease in platelet production, increase in platelet destruction or consumption, or
increase in splenic sequestration. The age-adjusted prevalence of immune thrombocytopenic purpura (ITP) is
estimated to be 3.3 per 100,000 persons in the USA, while drug-induced TCP affects 1-2 per 100,000 persons.
The majority (>95%) of TCP cases result from autoimmune disorders or are induced by chemo- and
radiotherapies as well as other pharmaceuticals. At platelet counts <50,000/μL, surgical procedures are
complicated by high bleeding risks and any minor injury may lead to excessive bleeding. At counts <10,000/μL,
spontaneous bleeding becomes a major concern. Therefore, frequent therapeutic and prophylactic platelet
transfusions are required to increase platelet counts and mitigate bleeding risks. However, the availability of
natural platelet products is severely limited by a near-static pool of donors and a very short shelf-life (3-5 days)
due to high risks of bacterial contamination and storage-related platelet activation and degranulation. Therefore,
there exists a significant unmet clinical need for a therapeutic agent that can mitigate bleeding complications
intravenously in TCP patients, while allowing reduced contamination and long shelf-life without compromising
function. To this end, we have developed a synthetic hemostatic nanotechnology, called SynthoPlateTM, that
mimics platelet’s ability to adhere and aggregate specifically at a site of injury in the body. In Phase I of this
SBIR, we demonstrated platelet-mimetic hemostatic functions in vitro as well as in vivo in proof-of-concept TCP
murine models of bleeding. Building on this in the proposed Phase II studies, we aim to: 1) Establish appropriate
clinical biomarkers for monitoring SP efficacy in thrombocytopenic (TCP) patient blood samples, 2) determine
the effective pharmacodynamic (PD) dosing window of SynthoPlateTM in a rabbit bleeding model of
thrombocytopenia, and 3) establish the pharmacokinetic (PK) profile of SP in healthy and thrombocytopenic
(TCP) rabbits. Altogether, these experiments will establish and correlate PK with ex vivo functional assays and
in vivo PD to guide clinical evaluation. Success in this Phase II proposal will be used to generate a Target Product
Profile (TPP), which will guide clinical protocol design, as well as aid in raising follow-on-funding and partnerships
for product development from multiple potential sources. Building on these results, Phase III will implement
defined dosage guidelines for IND-enabling Pharm/Tox studies with GMP-manufactured SP and thereby
progress towards submitting an IND application for clinical evaluation.

Public health relevance
Project Narrative Thrombocytopenia is a condition characterized by low platelet counts; patients with thrombocytopenia are at risk of excessive, uncontrollable bleeding. The current standard of care is transfusion with donor platelet products to mitigate bleeding risks. However, donor platelets are expensive, carry significant risk of infections, have variable hemostatic efficacy, and have very short shelf life (3-5 days). Our innovative SynthoPlateTM technology can mimic platelet’s hemostatic functions while providing advantages of large-scale production and sterilizability to reduce contamination risk and ensure long shelf life.